IN VITRO EFFECTS OF IL2 ON ACTIVITY OF NATURAL KILLER CELLS IN CFS

To characterize the suppression of natural killer cell activity in chronic fatigue syndrome by determining the activation of cytolytic activity with recombinant interleukin-2 from natural killer cells from CFS patient populations to determine if CFS is associated with reduction of natural killer cells and to evaluate resolution of fatigue.